MoTrPAC Genomics, Epigenomics and Transcriptomics Chemical Analysis Site Supplement

Project Summary
Physical activity (PA) has been shown to improve the overall health of human beings. The molecular mechanisms
responsible for the diverse benefits of PA are not well understood. The Molecular Transducers of Physical Activity
Consortium (MoTrPAC) is being formed to advance knowledge in this area. We propose to conduct
comprehensive analyses of the MoTrPAC human PA intervention samples, contribute these data to public
databases, help identify candidate molecular transducers of PA and elucidate new PA response mechanisms,
and help develop predictive models of the individual response to PA. The Genomic, Epigenomic, and
Transcriptomic assay site at Icahn School of Medicine at Mount Sinai and New York Genome Center (ISMMS
GET) provide the infrastructure, assay and analysis expertise and experience to support this large-scale,
comprehensive analysis of molecular changes associated with endurance and resistance exercise. ISMMS GET
aims are to 1. Work with the MoTrPAC Steering Committee and Biospecimens Committee to finalize analysis
plans and protocols for randomized human clinical trial study; 2. Generate high throughput GET data such as
high-depth RNA-seq and Whole Genome Sequencing (WGS), supplemented by additional assay types such as
ATAC-seq, Iso-Seq, and CITE-seq based on clinical human samples; 3. QC data and transfer to MoTrPAC
Bioinformatics Center (BIC) and perform initial analyses to help ensure data quality; 4. Collaborate with BIC and
other MoTrPAC sites to analyze animal and human data from GET and other MoTrPAC analysis sites to identify
candidate PA transducers and molecular mechanisms; 5. Integrate various omics data and develop predictive
models of PA capacity and response to training in humans; 6. Participate in the preparation of manuscripts and
presentations and make the results of the study available to the public using peer-reviewed publications in
scientific journals; 7. Make data generated in the study available to the scientific community through MoTrPAC
DataHub and Gene Expression Omnibus. The success of GET Sites and the MoTrPAC program will transform
insight into the molecular networks that transduce PA into health, create an unparalleled comprehensive public
PA data resource, and can provide the foundation for profound advances in the prevention and treatment of
many major human diseases.

Public health relevance
Project Narrative While physical activity prevents or improves many diseases, the chemical changes that occur in the body and lead to better health are not well known. As a part of a consortium of physical activity research programs working together, we will use advanced technologies to comprehensively study the changes in genes and gene products caused by physical activity. This study can potentially lead to advances in preventing and treating many diseases using physical activity.